Microbiome-based diagnosis of pneumonia in the acute respiratory distress syndrome

PROJECT ABSTRACT
This application is for a Mentored Patient-Oriented Research Career Development Award entitled
“Microbiome-based diagnosis of pneumonia in the acute respiratory distress syndrome”. I am a
Pulmonary and Critical Care Medicine Fellow at the University of Pittsburgh and I require additional training to
develop expertise as a translational researcher in the microbiome of critical illness. The central objective of my
research is to utilize emerging microbial DNA sequencing techniques for faster and more accurate diagnosis of
pneumonia in critically-ill patients. The focus of my research is the acute respiratory distress syndrome
(ARDS), a serious form of inflammatory lung injury often caused by pneumonia and accounting for 10% of
intensive care unit admissions in the US with 40% mortality. With diagnostic limitations of the current standard-
of-care of microbial cultures, patients often receive empiric, broad-spectrum antibiotics that can be
inappropriate or inadequate for their individual needs, and also promote antibiotic resistance – a major public
health threat. My preliminary data demonstrate feasibility and proof-of-concept that sequencing of microbial
DNA directly from patient samples can lead to faster and more accurate diagnosis of pneumonia compared to
cultures. The aims of the study are to develop sequencing-based definitions for pneumonia in (1) culture-
positive and (2) culture-negative patients by integrating microbiome and host response data, and then 3) to
assess the anticipated impact of sequencing on antibiotic selection. I will execute a prospective cohort study in
patients with ARDS and use modern culture-independent sequencing techniques and computational biology
methods to study the lung microbiome in relation to host-responses and microbiologic cultures. The proposed
sequencing-based approach has the potential to improve accuracy of pneumonia diagnosis (capturing both
cultivable and non-cultivable organisms) and to provide information to clinicians much faster than cultures.
Thus, my proposal addresses a high priority issue for development of innovative diagnostics of infections to
improve antibiotic usage and provides a unique translational training opportunity. I propose a research-
intensive period of career development with hands-on and didactic training in advanced sequencing
techniques, bioinformatics, computational biology and clinical trial design and implementation. The work will be
conducted within the Division of Pulmonary, Allergy, and Critical Care Medicine at the University of Pittsburgh,
which has an outstanding record of training physician-scientists and a highly-developed infrastructure for the
conduct of translational studies. I am supported by a committed mentoring partnership with convergent
expertise in microbiome and critical care research, and a diverse Mentoring Advisory Committee. With support
from the K23 Mentored Career Development Award, I will develop an independent project examining
sequencing-based pneumonia diagnostics for an R01 proposal over the next five years.

Public health relevance
PROJECT NARRATIVE Current diagnostic limitations of pneumonia in the acute respiratory distress syndrome result in “one-size-fits- all” antibiotic prescriptions, which can be harmful for individual patients and promote antibiotic resistance. In this proposal, we will utilize emerging microbial DNA sequencing techniques for the development of more accurate and faster diagnostics of pneumonia, with the goal of accomplishing precision antibiotic management in critically-ill patients.